Sending and transducing Hedgehog and Wnt signals

Project summary
The main focus of our lab is on deciphering key mechanisms involved in cell-cell signaling through the
vertebrate Hedgehog (Hh) and Wnt signaling pathways, which are essential for embryogenesis, adult stem cell
maintenance, and are deeply involved in cancer and birth defects. A secondary focus is the development of
chemical probes for various biological molecules (DNA, RNA, proteins, lipids) in cells and tissues; these
probes are critical in our work on cell signaling, but they are useful beyond.
In Hh and Wnt signaling, we primarily study the events at or near cellular membranes, because of the larger
questions still unanswered in this area. We are interested in understanding how cells send Hh and Wnt signals
(proteins referred to as Hh and Wnt ligands), how the signals travel to faraway cells, and how the target cells
receive and interpret these signals.
Both Hh and Wnt ligands are attached to lipids, a feature that makes them stick to cellular membranes, raising
the question of how they are released from producing cells. The same lipids are also essential for the signaling
activity of the ligands, by mediating binding to receptors on target cells; however, it has been unknown how the
lipid-modified ligands are delivered to their receptors and how they activate signaling.
In recent work, we discovered that both Hh and Wnt ligands have dedicated release pathways, resulting in the
formation of complexes between ligands and specific carrier proteins, that shield the water-repelling lipids from
the extracellular environment. We found dedicated pathways that receive these carrier-ligand complexes on
the surface of target cells, to allow ligand-receptor binding. We also discovered a unique mechanism by which
cholesterol plays a critical role in Hh signaling, and built novel chemical tools to study how cholesterol functions
in this context.
Our findings open several fundamental questions, which we propose to answer in the next 5 years, using a
combination of biochemistry, structural, chemical and cell biology. We propose to elucidate how the lipid
modifications of Hh and Wnt ligands are handled during the packaging of carrier-ligand complexes, which is
currently unknown. We will also determine how the target cells unpack the carrier-ligand complexes, and how
they promote ligand-receptor binding, to trigger signaling. Finally, we will dissect the role of cholesterol in Hh
signaling, which has remained mysterious.
These studies are important for the following reasons: A) They will advance understanding of the Hh and Wnt
pathways, by elucidating critical molecular mechanisms involved in signaling; B) They will identify novel targets
for blocking oncogenic Hh and Wnt signaling; and C) Our novel chemical probes will be broadly applicable to
study cholesterol in health and in disease.

Public health relevance
Project narrative The Hedgehog and Wnt cell-cell signaling pathways govern critical processes in embryonic development, adult stem cell maintenance, regeneration, and in the pathogenesis of several human cancers and birth defects. We propose to use biochemistry, structural, cell and chemical biology, to elucidate essential mechanisms that govern how the Hedgehog and Wnt ligands are released from producing cells, how they are delivered to their receptors, and how the signals are transduced in target cells. These studies will have broad impact on human health, by advancing our understanding of how certain types of cancer and birth defects develop, and by defining novel targets and strategies for cancer therapy.